The mechanism and role of erythrocyte invasion by Francisella tularensis

Francisella tularensis is one of the most infectious organisms as inhalation of a single
bacterium can lead to a fatal disease referred to as tularemia. It has therefore been categorized
by the Centers for Disease Control and Prevention as a Category A biodefense agent. Many
seminal studies have shown that the ability of F. tularensis to replicate within macrophages is
associated with the pathogenesis of this organism. In subsequent years, my laboratory helped to
move the field of Francisella research forward by illuminating that interactions with non-
macrophages are also extremely important during infection as these cells provide a sanctuary
from immunity, allow for bacterial proliferation, and provide protection from antibiotics. Although
much of the work in the field of F. tularensis has focused on the intra-macrophage biology of this
organism, interactions with other cell types have not been thoroughly investigated. Perhaps the
most surprising finding of our laboratory was the discovery that F. tularensis invades and persists
in erythrocytes. This invasion enhances the ability of F. tularensis bacteria to survive in ticks
(important disease vectors) following a blood meal. In this application, we will test the hypothesis
that erythrocyte invasion is required for long-term colonization of ticks and subsequent
transmission to mammals.
We have previously shown that the erythrocyte surface protein, Band 3 is required for
invasion and that interaction with this surface protein may be required for manipulation of the
spectrin cytoskeleton through Ankyrin-1. Moreover, we have shown that F. tulareniss bacteria
secrete PdpC into erythroyctes via the type VI secretion system (T6SS), and that this effector is
required for invasion. OpiA, another T6SS effector, is produced and accumulates in erythrocytes
during bacterial persistence. In this application, we will explore these aforementioned host and
bacterial proteins to gain insight into the mechanism of erythrocyte invasion and the persistence
within these host cells.

Public health relevance
The work described in this proposal will make substantial advances toward understanding how Francisella tularensis invades and persists within erythrocytes during infection. This investigations outlined in this proposal will also allow us to determine whether erythrocyte invasion is a transmission factor. Here, we will examine whether residing within an erythrocyte leads to long-term colonization of arthropod vectors and subsequent transmission to mammalian hosts.